Mental health phenotypes shaped by trauma exposure, symptom severity, and individual characteristics among recent Latinx immigrant adults

PROJECT SUMMARY/ABSTRACT
Exposure to violence and trauma in Latin America significantly contributes to migration to the U.S.,
bringing attention to the mental health consequences of forced migration at the U.S./Mexico border. Traumatic
events occur at every stage of migration and negatively impact mental health. Evidence suggests that Latinx
immigrants in the U.S. enjoy an initial health advantage that erodes over time spent in the country as
immigrants experience discrimination and are less likely to seek health and mental health care. Also, this
health advantage comes into question when analyzed by sub-groups. Insufficient evidence exists of the
intersection of trauma exposure; individual characteristics; and mental health outcomes of depression, anxiety,
and PTSD among recent Latinx immigrant adults. This K01 Award proposes a mixed methods design that
incorporates latent class analysis methods to develop mental health phenotypes of recent Latinx immigrants
based on the intersections of trauma, individual characteristics and mental health. This research will develop
ethical approaches to studying trauma and mental health cross-sectionally and set the foundation for future
prospective research of mental health phenotype evolution to inform intervention development and delivery.
This research has three specific aims: (1) Develop initial mental health phenotypes in a sample of
recent Latinx immigrant adults using latent class analysis methods and examine their demographic and trauma
exposure correlates (trauma exposure, sex, age, gender, marital status, education, country of origin and
ethnicity); (2) Provide an in-depth understanding of participant experiences of trauma exposure and mental
health to illuminate findings in SA1 using qualitative methods; and (3) Validate the phenotypes and any
additional constructs that emerge from qualitative data with a second survey sample of 313 recent Latinx
immigrant adults at the U.S./Mexico border.
My career development plan includes three Training Goals: (1) Develop comprehensive expertise in
structural equation modeling and latent class analysis methods as well as growth curve modeling and latent
transition analysis; (2) Gain extensive expertise in qualitative and mixed methods research at the intersection
trauma exposure, individual characteristics, and mental health of Latinx immigrants with an emphasis on space
and time.; (3) Develop expertise in ethical conduct of human research with a public health impact, that includes
understanding gender differences in trauma exposure, as well as recruitment and prospective retention of
vulnerable populations; and (4) Develop broad expertise in dissemination and translation of research with
immigrant populations for policy and practitioner audiences. This K01 Award will support my long-term career
goal of becoming an independent investigator conducting ethical longitudinal and intervention research on the
mental health of recent Latinx immigrants in the U.S. The research plan will produce data for a multi-site R01
prospective study on the trajectories of trauma exposure and mental health of Latinx immigrants to the U.S.

Public health relevance
PROJECT NARRATIVE This study will use a cross-sectional design and mixed-methods to examine mental health among recently arrived Latinx immigrant adults through the development of mental health phenotypes shaped by the intersection of trauma exposure, symptom severity (of depression, anxiety and PTSD), and individual characteristics. Extreme violence has been a main contributor to migration to the U.S. from Latin America. This K01 Award proposes to develop mental health phenotypes in this population in order to develop longitudinal studies on the evolving mental health of immigrants and inform the development and delivery of appropriate interventions for the right person at the right time.